Rare variants associated with AVSD in Down Syndrome

PROJECT SUMMARY
Congenital Heart Defects (CHDs) are the most prevalent structural birth defect, affecting 8-10 of every 1000 live
births and accounting for 25% of infant mortality. Infants born with a CHD often undergo many corrective
surgeries, which aim to restore normal cardiac function. Consequently, they spend much of their early-life in the
hospital, causing a large physical, emotional, and financial burden. These interventions, however, remain
restorative not curative, and infants with a CHD who survive into adulthood remain at risk for other comorbidities
that are associated with a “sick heart”. Understanding the pathways that are important for CHD pathogenesis
and normal heart development through genetic analyses would aid in the treatment/prevention of these defects.
One severe form of CHD that is of particular interest is the atrioventricular septal defect (AVSD). AVSD is rare
in the general population, affecting 1 in 10,000 euploid infants. By contrast, AVSD affects 1 in 5 triploid infants
in the Down Syndrome (DS) population. The 2000-fold increase in AVSD risk in DS suggests that dosage of
chromosome 21 is a principal risk factor for AVSD. However, since half of the infants born with DS have a
structurally normal heart, the extra copy of chromosome 21 alone is insufficient to cause AVSD, suggesting that
there may be other factors that modify this risk. Previous genome wide association studies (GWAS) of AVSD in
DS have established that common variants with large effect size do not fully explain the increased risk in AVSD
among DS. In addition, candidate gene studies based on genes implicated in CHDs have identified rare variants
associated with AVSD in DS, supporting a role for rare variants throughout the genome on AVSD pathogenesis
and justifying the use of whole genome sequencing (WGS) to increase discovery potential. Taken together, the
previous studies of AVSD in a sensitized DS population lead us to hypothesize that there is an increased burden
of rare variants that are incompletely penetrant on an euploid background which modify AVSD risk on a trisomy
21 background. This hypothesis will be tested in three independent but complementary aims in which we will
leverage WGS of individuals with CHD and DS, normal hearts and DS, and their euploid parents with structurally
normal hearts, and euploid individuals with CHD to: 1) identify rare variants with and without dosage effects on
chromosome 21 and 2) identify rare and de novo variants in the genome outside of chromosome 21 and 3)
determine the role of AVSD risk variants found in DS to euploid AVSD and other subtypes of CHD in DS. Our
long-term goal is to reduce the clinical burden associated with AVSD by identifying pathways that are vulnerable
to genetic changes and consequently open the possibility of modifiable targets to aid in the prevention and
treatment of AVSD. Notably, previous studies suggest that risk factors identified in the DS population are relevant
to the chromosomally normal population. Therefore, this project has broader implications for decreasing the
overall burden associated with AVSD, even in euploid infants.

Public health relevance
PROJECT NARRATIVE Congenital heart defects (CHD) are the most common and severe structural birth defects. One type of severe CHD is the atrioventricular septal defect (AVSD), which is rare in the general population but much more common in the Down Syndrome population. We will study AVSD and other types of CHD in children with Down Syndrome to understand the possible genetic modifiers of CHD in Down Syndrome.